CELL TYPE-SPECIFIC CONTROL of GENE EXPRESSION by RIBOSOMAL PROTEIN ISOFORMS

Project Abstract
Mutations affecting protein components of the ribosome, an organelle essential in all nucleated cells for
translating mRNA, underlie a growing list of congenital diseases. It remains unclear how various germline
defects in the ubiquitous ribosome cause highly dissimilar and tissue-specific pathologies. Potential clues to
this conundrum lie in recent reports that physiologic variation in ribosome composition can regulate translation
of specific genes, often with tissue-specific effects. This novel gene regulatory paradigm suggests a myriad of
mechanisms by which ribosomes affect development and cellular physiology that await discovery. Canonically,
each ribosome contains 80 ribosomal proteins (RPs), most of which are each assumed to be encoded by a
single gene. However, these RP genes have hundreds of little-understood splice variants, paralogs, and
pseudogenes genome-wide, some of which have open reading frames that could produce proteins partly
resembling canonical RPs. I hypothesize that certain splice variants, paralogs, and pseudogenes encode
alternative RP isoforms that are expressed under specific biological conditions, and form distinct ribosomes
with specialized roles in mRNA translation. Such a model could uncover combinatorially numerous possibilities
for ribosome diversity, and reveal functions of many poorly understood ribosomal genes. To test my
hypothesis, I will first characterize the RP paralog S27L as a paradigm model system of alternative RP
function. My preliminary work suggests that, during lactation, mammary luminal epithelial cells undergo a
dynamic switch by downregulating canonical RP S27 and upregulating its paralog S27L. This suggests that
S27L-containing ribosomes may specialize in translating genes relevant to epithelial differentiation or high-
volume protein synthesis. Second, I will develop the first systematic bioinformatic and proteomic pipeline to
comprehensively investigate alternative RP expression across many cell types and developmental stages. The
number of potential alternative RPs is vast, as is the number of biological conditions that may require their
functions. There is therefore a need for a high-throughput approach using cell type- and developmental stage-
resolved transcriptomic analysis to reveal conditions under which novel alternative RPs are expressed and
incorporated into ribosomes. I will subsequently use ribosome fractionation and mass spectrometry to
determine whether potential alternative RP transcripts are translated and incorporated into ribosomes in
primary mouse tissues. Together, these orthogonal aims set a precedent for exploring the considerable
potential impact of alternative RPs on development and health. Importantly, through this work I will gain diverse
expertise in cutting-edge experimental methods, computational techniques, and scientific reasoning, advancing
towards my goal as a physician-scientist to elucidate genetic mechanisms underlying human disease.

Public health relevance
Project Narrative Mutations in genes encoding ribosomal proteins, which together form the blueprint for basic molecular machinery critical for generating and maintaining all cell types in the body, can cause poorly understood and currently untreatable congenital and childhood diseases. Furthermore, these genes have many copies throughout the genome, and it is largely unknown whether or how these gene copies biologically function. In this project we will study whether these gene copies are active in different cell types and whether their functions differ from their canonical counterparts, towards the ultimate goal of revealing novel gene functions that impact human health.